Genetic-engineered control of the immunogeneic state of vascular composite allografts during preservation

PROJECT ABSTRACT. This is a design driven study to develop engineered VCA grafts by direct genetic
modification to test the efficacy in both detecting immune rejection and reducing immunogenicity in a porcine
model of graft rejection. A genetic construct with a transcription factor control element will serve as a biosensor
for reporting and therapeutically responding to the immunologic state of a graft. This synthetic gene switch
simultaneously drives the secretion of a blood-based biomarker and a therapeutic protein to attenuate a rejection
response. In our prior work and preliminary results, we have shown engineering of cells with all the required
response elements, a mathematical model that predicts in vivo transduction, direct genetic modification of VCA
tissue in rat limbs, and the first 24hr ex vivo pig VCA machine perfusion with a successful transplant in a
heterotopic porcine hindlimb model. The rationale here is to scale up the techniques based on our recent
successes in rodents, and test the proposed smart-graft approach in a clinically relevant graft rejection model in
pigs.
This application proposes the development of a functional preservation platform for engineering grafts
that feature theranostic biosensors for reporting and responding to the state of the graft. To enable the creation
of such grafts and their transplant in a clinically viable fashion, we propose to leverage machine perfusion
protocol to provide a functional preservation modality that will also enhance the logistics of VCA transplantation
by increasing the VCA storage time from the current limit of 6 hours to 24hours. The proposed work is significant
in two synergistic aspects: first, smart-graft technology that can sensitively measure local tissue signaling would
enable practical monitoring and diagnosis of acute rejection episodes, which remains elusive and critical from a
practical perspective to titrate the dosage of immune suppression in patients. Moreover, auto-delivery of anti-
inflammatory therapeutic molecules can transform care of transplant patients since compliance issues in
medication would be dramatically reduced, and moreover by delivering such therapeutics at a local and time-
sensitive manner will likely increase the overall efficacy and therefore reduce graft rejections. Second, from a
practical & logistical perspective, engineering VCA grafts will require an organ culture protocol that provides
access and time to achieve such manipulations. The proposed machine perfusion protocol provides the perfect
platform to achieve such timelines. In the long term, the methods developed here could also enable for tolerance
induction in VCA transplants, and therefore allow for their wide-spread use. Even more broadly, genetically
modified organs could extended ex vivo storage duration and provide the infrastructure required to extend HLA
typing to all grafts for global matching programs and improved transplant outcomes.

Public health relevance
Health Relevance In this work we propose to develop a novel smart graft engineering platform and validate in a porcine model of limb transplantation. The approach enables sensitively measuring local tissue signaling, and in turn either releasing a biomarker which can be practically monitoring to diagnose acute rejection, or can be used to trigger the release of a medication that would reduce immune response. Such smart grafts can transform care of transplant patients since compliance issues in medication would be dramatically reduced, and would likely increase the overall efficacy and therefore reduce graft rejections. In the longer term, the methods developed here could also be enabling for tolerance induction in VCA transplants, and therefore allow for their wide- spread use which is not possible currently.